Mechanisms of Lipid Droplet Formation

PROJECT SUMMARY
Lipid droplets (LDs) are ubiquitous monolayer-bound organelles that function in cellular lipid storage (for metabolic energy
or membrane synthesis). LDs form from the ER, but how LDs are formed remains unknown and is a central question for the
field. The current model indicates that neutral lipids, such as triacylglycerols (TG), are synthesized in the ER and released
into the bilayer. At a critical concentration, TGs de-mix from the phospholipid bilayer in a phase transition that forms
nascent LDs that bud toward the cytosol. We hypothesize that proteins are essential to ensure this process occurs in a
defined manner and to prevent the formation of “ectopic” and potentially dysfunctional LDs, disrupting ER and cell
function. Specifically, two ER proteins – seipin and lipid droplet assembly factor 1 (LDAF1) – operate in the lipid droplet
assembly complex (LDACs) in the ER to form LDs. Both proteins form an oligomeric assembly with seipin forming a ring
of 10-12 subunits and an equal number of LDAF1 occupying the middle of the ring. While we have identified components
of the LD formation machinery and gained some insight into their structures, how these proteins function to facilitate LD
formation remains mostly a mystery. Here we propose to utilize the latest tools and approaches, including biochemistry,
structural biology, molecular simulations, and cell biology, to address the following questions: How and where is TG made
relative to LDACs? What are the molecular structures of the seipin/LDAF1 LDACs? How do these oligomeric complexes
assemble/disassemble? Where do LDACs localize in cells? How do they function to organize LD formation? We will
address these questions by completing four specific aims. Aim 1 will address the mechanism of TG synthesis in the ER by
the DGAT1 enzyme. We will expand on our recent elucidation of the molecular structure of human DGAT1, combining
molecular dynamics and biochemical experiments to elucidate the precise mechanism of TG generation and determine how
TG is released into the ER membrane for LD formation. Aim 2 will determine how and where LD assembly complexes
assemble in cells to form LDs. We will determine the relationship of TG synthesis to LDACs, whether seipin/LDAF1
LDACs localize to ER tubules and how they assemble. Aim 3 will focus on elucidating the molecular structure of the
seipin/LDAF1 LDAC in vitro and in cells. We will utilize cell and structural biology approaches, including cryo-EM and
cryo-ET to test the hypothesis that seipin and LDAF1 form a ring structure with LDAF1 in center and that these LDACs
form at areas of membrane curvature (tubules) where the structure may adopt dynamic conformations and activate of the
complex. Aim 4 will determine the molecular function of the seipin/LDAF1 LDAC in vitro and in molecular dynamics
simulations. We will reconstitute LD formation to test the hypothesis that the seipin/LDAF1 LDAC catalyzes phase
transition of TG in the membrane, ensuring LDs form at these designated formation sites. Successful completion of these
aims will advance the molecular understanding of a fundamental process central to energy metabolism and provide
information on the mechanistic underpinning of many metabolic diseases, such as obesity, atherosclerosis, and fatty liver
disease.

Public health relevance
PROJECT NARRATIVE We are studying the basic biology underlying the formation of fat droplets in cells. This process is critical to meet the demands in cells for metabolic energy, but when uncontrolled leads to obesity, type 2 diabetes, fatty liver disease, and other metabolic diseases of fat excess. By understanding how these processes occur and are regulated, our work will advance our understanding of these conditions and may lead to new therapies to treat them.